Treatment for TIA to manage cardiovascular disease and diabetes in older adults

Abstract: Type 2 diabetes (T2DM) and cardiovascular disease (CVD) are important causes of morbidity and mortality in the elderly population in the United States, costing over $104 billion annually to the Medicare system. The average monthly cost for Medicare beneficiaries with T2DM is 2.2 times higher than that for a Medicare beneficiary without T2DM. Costs of CVD for a Medicare beneficiary with T2DM account for 50% of total costs to Medicare from CVD. Because of 1) the high prevalence of T2DM and CVD, 2) their high costs, 3) increasing longevity, and 4) the increasing number of Medicare-eligible individuals, understanding the trajectory of cardiovascular health in persons with diabetes is becoming increasingly important. However, many modern treatment paradigms, including carotid endarterectomy (CE) and carotid artery stenting (CAS), are based on studies performed before the widespread use of high-potency anti-platelet medications, statins, antihypertensive and glucose lowering medications to prevent CVD, and prior to recent smoking prevention and cessation interventions. We propose to develop a detailed model of cardiovascular disease in persons with diabetes, and to use it to update treatment paradigms for CE and CAS in individuals with TIA. Combining the Cardiovascular Health Study (CHS) and Atherosclerotic Risk in Communities (ARIC) data sets, we will develop risk equations for incident TIA and ischemic stroke following TIA in people with T2DM. The risk equations will depend on demographic descriptors, biomarkers, treatment history, and clinical history. We will calibrate and validate the equations to modern standards of care. The final risk equations will be integrated into the Michigan Model for Diabetes, providing a unified model of CVD (TIA, stroke, and heart disease). Using our CVD model, we will perform cost-effectiveness analysis of CE plus modern medical management (MMM) vs CAS plus MMM vs MMM without surgery and we will develop age-specific recommendations for treatment of TIA in older adults based on best-available evidence.

Public health relevance
Project Narrative With increasing longevity and the burgeoning population of Medicare-eligible individuals, it is important to understand the trajectory of cardiovascular health in persons with type 2 diabetes in order to define cost-effective methods to promote health as people age. We will develop a model of TIA incidence and its sequeli (including ischemic stroke, myocardial infarction, and death), and integrate the TIA model into a unified model of cardiovascular disease in persons with diabetes. We will then use this model to assess the cost-effectiveness of carotid endarterectomy and carotid artery stenting in individuals with TIA under modern standards of care in order to develop treatment recommendations.